Identification of Cyclic Peptide Antagonists of an Anti-Opioid G Protein-Coupled Receptor

Identification of Cyclic Peptide Antagonists of an Anti-Opioid G Protein-Coupled Receptor
RFA-DA-19-019 R43 Phase I SBIR
PI: Sid A. labed
Project Summary
The highly addictive properties of opioid drugs, coupled with routine over-prescription, have resulted in a
national crisis. Accidental overdose by opioids has increased over 400% in the last 15 years, from ~8,000 opioid-
related overdoses to more than 30,000 in 2015. The staggering cost of the opioid health crisis to the American
public exceeds $50 billion annually, highlighting the need for safer therapeutics for pain management. Drs. Kirill
Martemyanov and Brock Grill at the Scripps Institute, Florida, have engineered a model system expressing a
functional mammalian opioid receptor (MOR) in the model nematode Caenorhabditis elegans for discovery of
opioid modulators. Using this system, they identified an orphan G Protein Coupled Receptor, GPR139, as a
negative regulator of MOR signaling. In mammals, GPR139 is co-expressed with MOR in opioid-sensitive brain
regions and influences MOR trafficking and signaling. Deletion of GPR139 in mice enhanced opioid-induced
inhibition of neuronal firing, increased the analgesic and rewarding effects of morphine, and reduced withdrawal.
Previous efforts to target GPR139, which have largely focused on identification of small molecule agonists,
has failed to produce a therapeutic candidate antagonist with favorable pharmacological properties. To address
this unmet need, EvoDenovo will screen an innovative library of cyclic peptides (CPs) for new GPR139
antagonists by combining two state-of-the-art C. elegans technologies exclusive to EvoDenovo: 1) InVivo
Display: a high-throughput screening technology invented by EvoDenovo that can be used for peptide-based
drug discovery that bypasses the necessity of peptide purification by directly feeding live recombinant E. coli
clones, each expressing a different cyclic peptide, directly to nematodes expressing mammalian MOR and
human GP139. This drastically reduces the cost and time for screening. 2) The anti-opioid behavior platform
developed at Scripps by Drs. Martemyanov and Gril that assesses the behavioral effects of opioids and identifies
pharmacological outcomes of different drugs. The combination of both platforms, assisted by an automated C.
elegans movement tracking system, will yield a powerful high throughput screening engine capable of
interrogating thousands of recombinant peptides within a few days, all in a unique in vivo setup. GPR139
antagonists identified using this assay would likely be missed by conventional screening protocols. EvoDenovo
uses CPs instead of linear peptides. The cyclization of peptides increases gut stability by eliminating vulnerable
N- and C-termini, reduces susceptibility to proteolytic hydrolysis, and enhances membrane permeability.
There are 2 specific aims: Aim 1: Perform a behavioral screen for cyclic peptide antagonists of GPR139 in
C. elegans. Aim 2: Validate hits generated from the C. elegans platform in mammalian cell-based assays. This
Phase I proposal will provide the foundation for a Phase II SBIR which will include a larger-scale screen and
follow-up on prioritizing CP hits, mammalian testing, and IND enabling studies.
EvoDenovo RFA-DA-19-019/ PI: Sid A. Labed Project Summary - Page 1 of 1

Public health relevance
Identification of Cyclic Peptide Antagonists of an Anti-Opioid G Protein-Coupled Receptor RFA-DA-19-019, R43 Phase I SBIR PI: Sid A. Labed Project Narrative Accidental overdose by opioids has increased over 400% in the last 15 years, from ~8,000 opioid-related overdoses to more than 30,000 in 2015, highlighting the need for safer therapeutics for pain management. Nearly all FDA-approved medications prescribed for severe pain target the mu-opioid receptor (MOR). EvoDenovo is developing a discovery pipeline to identify and validate first in class peptide-based antagonists of GPR139, a novel receptor inhibitor of MOR, which, when blocked, mitigates the adverse effects of opiods, thereby reducing their abuse liability. EvoDenovo RFA-DA-19-019/ PI: Sid A. Labed Project Narrative - Page 1 of 1